Closed-loop attention bias modification brain training for opioid use disorder

Project Summary / Abstract
Significance: In 2021, more than 75,000 people in the United States died from opioid overdoses. Clinics that
treat Opioid Use Disorder (OUD) lack Food and Drug Administration (FDA)-regulated devices that can be
prescribed to alleviate cravings and prevent drug use and overdoses. The objective of this SBIR Phase I
project is to develop and test a portable neurotherapeutic device that reduces drug craving processes using
brain training. Innovation: Craving and drug use following OUD treatment are precipitated by patients’
“attention bias” towards people, places, and things associated with prior drug use. For example, encountering
a pill bottle may evoke intensified attention towards additional drug-related cues, leading to physiological
craving and drug-seeking behavior. Attention Bias Modification (ABM) is a therapeutic approach that trains
patients’ attention away from triggers for drug use (e.g., pill bottle) and towards natural, non-drug-related
scenarios (e.g., prosocial cues), curtailing drug use and overdose. Neurotype Inc. will develop Modit-AB™, a
neurotherapeutic device that uses closed-loop neurofeedback and mobile electroencephalogram (EEG)
headsets to modify drug-related attention biases in OUD. Specific aim 1: in 15 healthy controls and 15
abstinent OUD inpatients, we will evaluate the technical feasibility of 3 types of ABM integrated with real-time
neurofeedback using the Modit-AB™ prototype. Here, the effects of ABM neurofeedback on neurobehavioral
measures of attention and attention bias will be evaluated. Specific aim 2: we will assess the expectations,
perceptions, and user criques of Modit-AB™ using a “Future Workshop” co-designing approach with clinicians
(n = 10) and patients (n = 20) from participating OUD treatment programs. Clinician and patient feedback will
guide device design. Expected outcomes: the technical and commercial feasibility of Modit-AB™ will be
determined by its ability to successfully modify drug-related attention biases and craving processes in patients
with OUD at the point of care (e.g., clinic office, waiting room). Finally, we will conduct a pre-submission
meeting with the FDA to clarify Modit-AB™’s regulatory pathway and plan for the SBIR Phase II project.
Investigators: Neurotype Inc. and its team of collaborators includes experts in clinical neuroscience, addiction
medicine, EEG brain monitoring, product development, software engineering, healthcare, and regulatory
matters.

Public health relevance
Project Narrative Neurotype Inc. is developing Modit-AB™, a novel neurotherapeutic designed to prevent drug craving and drug use in Opioid Use Disorder (OUD). Modit-AB™ combines promising attention neurofeedback approaches and low-cost mobile brain sensing technologies to train patients’ attention away from triggers for drug use (e.g., pill bottle) and towards naturally rewarding environments (e.g., prosocial scenes). Based on Food and Drug Administration and stakeholder feedback, Modit-AB™ will be sold to OUD treatment programs to support therapy and protect patients from harms such as relapse and overdoses.